Unraveling the synaptic and circuit mechanisms underlying a plasticity-driving instructive signal

PROJECT SUMMARY
Learning, fundamental to cognition, requires storing of information in flexible neural activation patterns
and synaptic weight changes (i.e., plasticity) within neuronal ensembles. These representations are
modified with experience on the timescale of seconds to minutes and even lifetimes. Although recent
pivotal work has provided insights into how population activity drives memory-guided behaviors, many
fundamental questions remain about the neural plasticity mechanisms that underlie the formation of these
representations in response to new experiences. The standard synaptic plasticity rule (i.e., spike timing-
dependent plasticity, STDP) requires precisely timed and repetitive pre- and postsynaptic activation,
which is incongruent with the seemingly chaotic activity of networks in awake behaving animals. In
contrast, behavioral timescale synaptic plasticity (BTSP), a learning rule I recently co-discovered to
underlie the development of experience-dependent spatial representations in hippocampal CA1, requires
only a single induction trial and operates on the cognitively relevant timescale of seconds. Thus, BTSP
provides one of the first biologically plausible mechanisms for how a single experience can produce
learning-related changes in brain activity. This previous research has positioned my laboratory to address
fundamental questions regarding the circuit and synaptic mechanisms underlying learning. Building upon
my published work, this proposal will test the model that the medial entorhinal cortex layer 3 (mEC3)
serves as an instructor, providing a context-specific target signal to CA1 neurons via their tuft dendrites,
thereby driving BTSP and directing the CA1 network in how to form a learning-related representation.
Specifically, we will determine how the mEC3 produces this target signal. We will first use extracellular
recordings with Neuropixels probes to monitor the neural activity from large populations of medial
entorhinal cortex (mEC) neurons in awake mice during a flexible spatial memory paradigm that allows
control over the learning time course. Using this approach, we will determine the flow of information
through the mEC network. Second, we will use in vivo whole-cell recordings of mEC3 neurons during the
same learning task to pinpoint the single-cell computations underlying the instructive signal. We will
identify the processes involved, which may include changes in excitability, synaptic input integration, and
plasticity. Third, we will combine activity recording techniques and optogenetics to determine the extent
to which the instructive signal is produced by local computation or inherited from upstream cortical
regions. This proposal will have a far-reaching influence on cellular, systems, and cognitive neuroscience.
As learning is a fundamental component of virtually all major brain functions, understanding the neural
algorithms of learning, from synaptic to population level neural coding, will provide a basis for
understanding how the brain performs all complex tasks that depend upon learning.

Public health relevance
PROJECT NARRATIVE Estimates suggest that more than six million Americans, most of them age 65 and older, may have Alzheimer’s disease, a brain disorder that affects the hippocampal formation early and is associated with devastating memory, learning, and other cognitive impairments. Understanding the plasticity mechanisms underlying the brain’s memory system may prove critical towards achieving rational progress in finding an effective treatment for the learning deficits observed in Alzheimer’s patients. This proposal will illuminate the synaptic, cellular, and circuit processes that underlie the entorhinal- hippocampal circuit’s crucial role in driving learning.